Expanding access to MOUD for patients in the emergency department: research and coordination

Project Summary/Abstract
Despite being associated with increased survival and decreased drug use, emergency department (ED) initiation
and prescription of medications for opioid use disorder (MOUD), including buprenorphine, for opioid overdose
and untreated opioid use disorder (OUD), is not yet commonplace in the United States, most likely due to
provider/healthcare system factors (e.g., lack of training, uncodified guidelines, and regulatory barriers) and
patient/family factors (e.g., stigma). Thus, our highly experienced, multidisciplinary research team proposes a
mixed-method quality improvement study, based on the California (CA) Bridge model, in a high volume ED
(where we estimate that buprenorphine was initiated with only 20% of likely patients with OUD in 2024) to
increase such care, along with establishing a national coordinating center (CC) that will produce an evidence-
based guideline and provide training, technical assistance, and resources to all collaborating centers. The
University of Arizona’s Prevention Research Center will partner with Banner Health and the Comprehensive
Center for Pain and Addiction to complete our specific aims. Aim 1. (Research Project) Implement a SUN
(substance use navigator) to increase ED OUD screening, MOUD initiation/prescribing, and linkages to
care. Using electronic health data, we will examine percentage change over time in (a) screening/diagnosis
(ICD-10 codes), (b) MOUD initiation and prescribing, and (c) linkage to post-discharge treatment within 7 days
to increase ED provider knowledge for identifying and treating patients with OUD as measured by increases in
rates over time. Aim 2. (Research Project) Investigate various structural factors that influence
implementation, scalability, and sustainability (e.g., precise documentation of the ED champion’s types and
categories of activities, an annual survey with ED personnel regarding the utility of the ED champion’s activities,
and an examination of reimbursement data and support for appropriate documentation) to produce an effective,
sustainable and replicable protocol. Aim 3. (CC) Evaluate the ability of the respective healthcare systems
of the network-affiliated collaborators to provide MOUD administration directly to patients until their
outpatient intake appointment or for 7 days (e.g., conduct a focus group with all collaborating centers to
identify barriers, create actionable strategies to overcome those barriers, invite the collaborating centers to
implement one strategy, and evaluate their progress in making changes) to create an evidence-based guideline
for healthcare systems to provide patients with MOUD at discharge. Aim 4. (CC) Among network-affiliated
collaborating centers, evaluate the provider-focused implementation strategies (e.g., SUNs, ED
Champion, or other similar strategies) that facilitate ED clinician prescribing and linkage to care within
7-days. Through measures such as the documentation of each collaborating center’s implementation plans,
quarterly updates of the types and number of implementation strategies, and network-wide feedback, we expect
to increase the number of ED clinicians who initiate medication.

Public health relevance
Project Narrative There is consensus among the nation’s principal medical and public health organizations that emergency departments (EDs) should initiate and prescribe medications for opioid use disorder (MOUD), including buprenorphine, for opioid overdose and untreated opioid use disorder (OUD), which has been linked to reduced morbidity/mortality, decreased drug use, and improved outpatient treatment linkages. Despite available models for implementing such lifesaving ED and post-discharge care, however, it is not taking place in the majority of EDs in the United States, most likely due to provider/healthcare system factors (e.g., lack of training, uncodified guidelines, and regulatory barriers) and patient/family factors (e.g., preferences and stigma). Therefore, our highly experienced, multidisciplinary research team is proposing to undertake a mixed-method quality improvement study in a high volume ED to increase such interventions by increasing essential ED provider knowledge and producing a replicable standardized protocol that identifies effective and sustainable strategies, along with establishing a national coordinating center that will produce an evidence-based guideline for healthcare systems to provide patients with MOUD in the ED and at discharge as well as providing training, technical assistance, and resources to all of the collaborating centers in the emerging, CDC-sponsored Overdose Prevention and Treatment Research Network (OPTRN).